Gaps and Determinants in PrEP Uptake and Need: Understanding Disparities in PrEP Among Women in the United States

ABSTRACT
Women accounted for 18% of new HIV diagnoses in the United States in 2020 and yet only 7.4% of the pre-
exposure prophylaxis (PrEP) users. Additionally, 71% of the women diagnosed with HIV in 2020 were
Black/African American or Hispanic. PrEP has been shown to reduce incident HIV infection, providing a
substantial public health opportunity to work towards the US Department of Health and Human Services
announced the Ending the HIV Epidemic initiative. However, a substantial component of risk of HIV infection for
women relates to the behaviors of their male sex partners, and these risks of partners may be unknown to
women. Additionally, the completeness of data on race/ethnicity in key datasets used to document PrEP users
in the US is limited leading to bias in our estimates. The proposed analysis will (1) determine the characteristics
of women based on their partnerships that are indications for PrEP, particularly those indications unrecognized
by women and their healthcare providers, 2) use multiple imputation to complete race/ethnicity data in current
pharmaceutical use datasets to better understand the current racial/ethnic distribution of women PrEP users,
and 3) analyze spatio-temporal patterns of PrEP uptake among women in the United States. Taken together,
the goal of this proposal is to advance our understanding of among whom PrEP is needed, racial/ethnicity
distributions among whom PrEP is currently being utilized, and where uptake is disparate considering risk factors
for HIV infection.

Public health relevance
PROJECT NARRATIVE Women constitute 18% of new HIV infections in 2020, and 71% of these were among Black/African American and Hispanic women and yet only 7.4% of PrEP users are women. To understand PrEP equity for women overall, it is essential to evaluate better methods to identify women with PrEP indications, to stratify them by race and ethnicity, and to determine how characteristics of women with PrEP indications vary geographically. We propose to conduct analyses on existing datasets to 1) to better understand the characteristics of women with indications for PrEP, particularly those indications unrecognized by women and their healthcare providers, and re-estimate the number of heterosexual women with PrEP indications, 2) to determine the current racial/ethnic distribution of women PrEP users including creating imputation models for missing data, and 3) to determine spatio-temporal patterns of PrEP uptake among women in the US.